Roles of DPA derived specialized pre-resolving mediators during vertebrate hematopoiesis

Blood disease, including anemia, blood clotting, and blood cancers, affects millions of people worldwide each
year, causing tremendous economic and social burdens. The American Cancer Society estimated 178,520 blood
cancer cases in 2020 in America and approximately 5,600 patients died of anemia in 2019 in the US. Our country
faces at least a 45 billion dollars economic burden annually due to blood related diseases. However, the current
treatments of blood-related diseases only palliate the symptom and temporarily prevent the disease progression.
The goal of this project is to investigate the roles played by specialized pro-resolving mediators (SPMs) derived
from polyunsaturated fatty acid (PUFA) n-3 docosapentaenoic acid (DPAn-3) during vertebrate hematopoiesis
and evaluate in vivo their therapeutic potentials for blood disorders. I performed chemical screen in zebrafish
embryos using several ecosanoid derived SPMs and whole-mount in situ hybridization (WISH) to identify
compounds that are able to increase Hematopoietic stem cell (HSC) and red blood cell (RBC). This screen
identified two promising SMP compound hits: 7,17 dihydroxy DPA (7,17 diHDPAn-3) and 19,20 epoxy DPA
(19,20 EpDPA). In this proposal I will evaluate their effects on the proliferation of downstream hematopoietic
lineages, including myeloid and lymphoid lineages by exposing wild-type zebrafish embryos to 1.5 µM 7,17
diHDPAn-3 and 2.5 µM 19,20 EpDPA from 11-36 hours post fertilization (hpf). After fixation, I will perform WISH
and real-time quantitative PCR (RT-qPCR) using c-myb, gata1, l-plastin, lyz, mpeg, rag1 and CD79 mRNA
probes and primers to descriptively and quantitatively evaluate the resulting effects of the two SPMs exposure
on the proliferation of hematopoietic stem cells, progenitor erythroid, granulocytic cells, neutrophils, and
macrophages, T and B cells respectively. Our preliminary data show that both 7,17 diHDPAn-3 and 19,20 EpDPA
promote HSC proliferation, increase RBC progenitors and RBC number, and increase neutrophil cell number.
Therefore, I hypothesize that 7,17 diHDPAn-3 and 19,20 EpDPA exposure enhances HSC proliferation,
increasing downstream mature blood cell types in vertebrates. To test our central hypothesis, I developed
the following two specific aims: Aim 1. To test the hypothesis that the two selected SPMs increase HSC number,
leading to increases in myeloid-derived cell and lymphoid-derived cell numbers and Aim 2. To test the hypothesis
that the two selected SPMs can be used as therapeutic interventions in disease models such as bacteria-
mediated infection, hematopoiesis genetic diseases, and post-irradiated adult zebrafish. This work will
characterize the roles of these two SPMs during vertebrate hematopoiesis and will test their therapeutic potential
in vivo. The outcome of this proposal will discover an unknown role for these two SPMs in regulating
hematopoiesis, opening a new road to developing a novel therapeutic therapy for blood-related diseases.

Public health relevance
Hematopoietic stem cells supply the lifelong foundation of the blood and immune systems and dysregulation in hematopoiesis gives rise to a variety of blood related diseases and cancers. We have identified two natural fatty acid mediators called specialized pro-resolving mediators that are able to increase hematopoietic stem cell number and hematopoiesis. This proposal will address how specialized pro-resolving mediators are able to increase hematopoiesis in vivo and assess their therapeutic potential for blood related diseases and cancers.